Optimization of microtubule-stabilizing triazolopyrimidines as therapeutics for Alzheimer's disease and related tauopathies

Statement of Work
Specific activities overseen by the Brunden laboratory include: 1) testing of prodrugs in established
HEK293 and neuron microtubule stabilization assays; 2) intravenous and oral pharmacokinetic testing of
prodrugs to determine the rate of conversion of prodrugs to the desired active compound; 3) assessment of
preferred prodrugs for pharmacodynamic effect in wild-type mice to establish the minimum effective
dose and duration of compound effect; and 4) determination of preferred prodrug acute maximum
tolerated dose and the no adverse effect dose after 3 weeks of dosing.